Safety and Cognition in Driving (SCID): A proposal to examine functional driving skills in professional drivers in Cape Town.

PROJECT SUMMARY Background. Some of the most common chronic medical conditions that may affect cognition negatively are HIV and metabolic syndrome (MetS), specifically diabetes and hypertension; yet there is limited information available on how these conditions may affect performance in the workplace. Because these conditions are often co-occurring and becoming more prevalent, it is important to gain understanding of how it affects society, vis-à-vis the work place, and its

Public health relevance
PROJECT NARRATIVE HIV and metabolic syndrome, of which both may affect cognition negatively, are some of the most common chronic medical conditions in younger and middle-aged adults in South Africa, and can negatively affect vocational functioning. There is a significant need to understand how the impact of less than expected cognition in these disorders affect society vis-à-vis the work place.